Structures and Pharmacology of Cation-Chloride Cotransporters

Project Summary
Human secondary active cation-chloride cotransporters (CCCs) fall into two classes: three Na+-dependent Na+-
(K+)-Cl- (NCC and NKCC1-2) and four Na+-independent K+-Cl− (KCC1-4) transporters. CCCs catalyze
electroneutral symport of Cl- with Na+ and/or K+ across membrane and are fundamental in cell volume regulation,
trans-epithelia ion movement, regulation of intracellular [Cl-]i and neuronal excitability. In the nervous system,
NKCC1 and KCC2 are the major Cl- loader and extruder, respectively, and their opposing actions move [Cl-]i
away from electrochemical equilibrium so that inhibitory neurotransmitters can evoke either inward depolarizing
or outward hyperpolarizing Cl- currents via pentameric ligand-gated ion channels. Mutations in KCC2 or KCC3
cause seizure, epilepsy, and other brain disorders possibly owing to an imbalance in excitatory versus inhibitory
synaptic transmission. Pharmacological tuning of NKCC1 and KCCs transport activities thus represents a
promising therapeutic strategy to restore synaptic inhibition for the treatment of brain disorders. In the kidneys,
NKCC2 and NCC reabsorb ions from the forming urine, balancing electrolytes and blood pressure. CCCs are
regulated by the WNKs-SPAK kinase cascade in response to hormone stimulation and cell volume perturbations,
with N(K)CC activated and KCCs inhibited by phosphorylation. Mutations in NKCC2, NCC, or WNKs and their
upstream E3 ubiquitin ligase regulators lead to hypotensive Gitelman's and Batter's syndromes or hypertensive
Gordon's disease. Loop and thiazide diuretics antagonize NKCC2 and NCC, respectively, and are widely
prescribed for the treatment of hypertension and edema. Building on our success in determining structures of
both NKCC1 and KCC transporters in multiple states, we now propose to determine a series of new CCC
structures using single-particle cryo-EM and to perform complementary biochemical and functional studies to
elucidate: 1) how CCCs alternate between different transport states to shuttle ions across membranes, 2) how
diuretic drugs interact with and inhibit CCCs, and 3) how (de)phosphorylation regulates CCC ion transport
pathways. In parallel, we will also develop and apply cell- and liposome-based flux assays that will accelerate
our CCC functional studies and, ultimately, could support high throughput screening platforms for rapid discovery
of small molecule pharmacological tools to dissect CCC structures/functions and provide drug leads to treat
hypertension, edema, and brain disorders. Our overarching goals are to combine structural, functional, and
pharmacological approaches to understand the inner-workings of CCCs and to facilitate rational targeting of
these transporters for the treatment of numerous human diseases.

Public health relevance
Project Narrative The secondary active cation-chloride cotransporters (CCCs) play fundamental roles in salt handling by the kidneys and inhibitory synaptic transmission in the nervous system. In this proposal, we will combine structural, biochemical, functional, and pharmacological approaches to elucidate how CCCs orchestrate concerted conformational changes to shuttle ions across membrane, how they interact with anti-hypertensive inhibitory diuretics, and how they are regulated by cognate kinases and phosphatases in response to hormones and cell volume perturbation. Successful outcomes will facilitate the development of novel therapeutic strategies for the treatment of hypertension, edema, and various brain disorders and psychiatric conditions.